FLUROSCOPY/DIGITAL SUBTRACTION ANGIOGRAPHY UNIT

This application requests funds to purchase a digital subtraction angiography/fluoroscopy unit to be utilized in the Cardiovascular Center at the University of Iowa. The unit will serve as a core laboratory facility to be utilized by four major users who have established research programs with significant research support from the National Institutes of Health. In addition, the Cardiovascular Center in the aggregate at Iowa has 5.5 million dollars in annual research support, most of which comes from the National Institutes of Health. Although the Cardiovascular Center at Iowa has extensive research facilities, there is no facility that allows investigators to obtain angiographic data from experimental animals. This critical equipment deficiency hampers the work of many Center investigators and would be remedied by the acquisition of a digital subtraction angiography/fluoroscopy unit requested in this application. The requested equipment acquisition would improve the quality, quantity and depth of cardiovascular research studies that can be performed in the Cardiovascular Center.